Investigating local protein co-translational folding in situ with high spatiotemporal resolution

Abstract
The folding of many proteins occurs co-translationally and involves the orchestration of numerous cellular factors,
including a large set of ribosome-associated proteins and chaperones. In the co-translational folding process,
the folding is intimately coupled to translation. If the ribosome elongates too fast or stalls for too long at the wrong
place and time, folding kinetics can be severely perturbed, leading to protein misfolding and/or aggregation. In
extreme cases, this can lead to diseases. A better understanding of protein co-translational folding kinetics in
the native context of translation is therefore critical to human health. The major challenge in the field is the lack
of spatiotemporal resolution needed to track and quantify co-translational folding in a living intracellular
environment. To address this challenge, we have developed a novel co-Translational Folding Tracking (coTFT)
technology that enables us to directly visualize co-translational folding with single mRNA precision and sub-
second resolution in living cells. With coTFT, we will focus on investigating co-translational folding in living cells.
Specifically, we will quantify the kinetics of co-translational folding occurring in diverse intracellular environments,
such as in cytosol and on the surfaces of organelles, to identify any location heterogeneity in co-translational
folding as well as heterogeneity in mRNAs in each location. Then we will further investigate an ongoing question
in the protein co-translational folding field – how alterations in translation elongation rate affects folding. Moreover,
we will develop a novel method that specifically labels and isolates the short-lived co-translational folding
complexes with high spatiotemporal resolution, which is challenging to achieve with current technologies. We
will apply this method to investigate the interactome that is highly specific for co-translational folding in diverse
subcellular environments. For discovered novel interactors, we will study their impact on co-translational folding
using our established coTFT technology. The discoveries from this study will help us further understand co-
translational folding in a native intracellular environment. In addition, our developed technologies are highly
adaptable. In the long run, we expect to adapt our technologies to study a group of disease related
transmembrane proteins and discover general as well as target-specific regulation mechanisms of co-
translational folding. The discovered novel regulation mechanisms have the potential to lead to new therapeutics
that have never been explored before for protein misfolding-related diseases.

Public health relevance
Narrative In this study, we will apply our developed co-Translational Folding Tracking (coTFT) technology and our established model to directly visualize and study local protein co-translational folding in living cells with high spatiotemporal resolution. In parallel, we will develop a novel method that enables us to uncover the interactome of co-translational folding labeled with high specificity to identify key interactors and further study their regulation on co-translational folding using coTFT. Our study will help us deeply understand co-translational folding regulation and therefore has the potential to lead to novel therapeutics for diseases caused by protein misfolding.